COURSEWORK GRANT: BIO 640: INTRODUCTION TO BIOINFORMATICS AND GENOMICS RESEARC

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. This course provides an introduction to select topics in genomics and bioinformatics, and focuses on the use of an array of biological databases and bioinformatics tools used for the retrieving and analyzing sequence data of DNA, RNA, proteins and genomes. The goal of this course is to enhance the potential of students to use bioinformatics tools in research and to make new discoveries in the area of genomics. A substantial amount of material that we use in this course is based on the exercises produced by the NIH supported MARC Bioinformatics Program staff at Pittsburgh